Acquisition of a digital autosampler-equipped N2-cryo 500 MHz NMR spectrometer

Project Summary/Abstract
This grant will purchase a Bruker AVANCE NEO Nuclear Magnetic Resonance (NMR) console and magnet
operating at 500 MHz proton frequency ﬁtted with an automated sample changer and equipped with a
cryogenically nitrogen-cooled detection probe. This autosampler-equipped cryo-N2 500 MHz NMR spectrometer
will be used to advance the research programs of our synthetic organic, inorganic, physical, and chemical biology
research community by providing basic critical infrastructure through the efﬁcient and accurate analysis of small
organic, peptide, and organometallic molecules. This instrument will be used by researchers who have signiﬁcant
NIH funding.

Public health relevance
Narrative This grant will purchase an autosampler-equipped cryo-N2 500 MHz NMR spectrometer. This instrument will enable efﬁcient and accurate analysis of small organic, peptide, and organometallic molecules to provide critical infrastructure to support research in human health and biomedical research.